Patient Safety Learning Laboratory to Enhance the Value and Safety of Neonatal Interfacility Transfers in a Regional Care Network

Project Summary/Abstract
The overall goal of this project is to establish a Patient Safety Learning Laboratory to advance patient safety for
critically ill newborns during medical ground or air transport from one hospital to another within a regional
network. The project will use a five-stage innovation cycle, including: problem analysis, design, development,
implementation, and evaluation to identify and address the salient issues and risks of regional neonatal
transportation for which new and innovative approaches are needed.
In collaboration with transport providers and other stakeholders, we will analyze current workflow processes,
transport records (local and statewide databases), and facilities at referral and receiving facilities to develop a
complete understanding of system issues and to define the current and ideal states. This detailed problem
analysis phase will enable the redesign of clinical workflow processes to optimize regional consultation, triage,
and transport of newborns to facilities with the appropriate level of care and availability of space and staffing.
With the input of clinical transport team staff and stakeholders, the project team will work with collaborators from
the University of Washington Industrial and Systems Engineering Department to design and develop a novel,
secure, Transport Monitoring and Communications (T-MAC) system to enhance video communication while on
transport. The T-MAC system will undergo repeated testing and revision to ensure that it can functionally and
efficiently facilitate information flow between the medical control physician, referring facility and transport team.
In addition, we will develop robust documentation processes that can conveniently be used during the transport
that includes checklists that prompt safety behaviors and provides a robust dataset for tracking adverse patient
safety events. To accomplish this, we will work with transport team providers to create forms that are suitable for
electronic documentation with the goal of streamlining documentation on transport and facilitating identification
of transport-specific safety issues.
The efficacy of the T-MAC system will be evaluated in a realistic in situ and data-driven 3D visualization models.
We are confident that the lessons learned through this study will improve neonatal patient safety on medical
transports and will be transferable to patient populations that undergo medical ground or air transports over large
geographical regions.

Public health relevance
Project Narrative This project expands the knowledge on patient safety for neonates by bringing together neonatologists, general pediatricians, nursing, transport teams, parent representatives, design specialists, and engineers. Methodologies that will be used include clinical workflow process evaluation using quality improvement methodologies, and Lean UX and agile methodologies for the design and development of a novel Transport Monitoring and Communication (T-MAC) system with integrated communication and continuous data capture to enhance neonatal patient safety on multi-state transports.